DEFEROXAMINE AND GALLIUM NITRATE IN PATIENTS WITH PROSTATE CANCER

The goal of this study is to determine the safety of deferoxamine and gallium nitrate in patients with hormone-refractory metastatic prostate cancer.